Wireless withdrawal detection and monitoring system for neonatal abstinence syndrome.

PROJECT SUMMARY
Neonatal abstinence syndrome (NAS) is an opioid withdrawal syndrome that develops shortly after birth to in utero-
exposed neonates. The cost of NAS is high: newborns with NAS are typically receive care in the Neonatal Intensive Care
Unit (NICU), where the daily cost of care is high. Nearly 22,000 infants are born with NAS each year at a cost of $1.5
billion. Moreover, medication-based interventions for the treatment of NAS, used in up to 80% of opioid-exposed
infants, carry their own risks of toxicity and drug interactions2. Despite the medical cost, high societal impact of NAS,
and the risks of treatment, the tools to assess the severity of NAS can be subjective and suffer from examiner bias. There
is an urgent need for innovative new methods to diagnose NAS and assess the efficacy of responses to treatment.
Flexible, low-cost wearable devices (worn on the skin) that can report measures of systemic biochemical and
biomechanical processes offer a simple and economical solution. In NAS, surges of sympathetic nervous system activity
produce increased heart rate, skin conductance, unstable temperature, and tremor. These manifest in increased infant
sweating, seizures, tremors, unstable body temperature, and more—events that must continually monitored and
assessed by nurses. The unsupervised, objective detection/quantification of the bodily response of neonates suffering
from NAS could drive the development of new, objective scoring tools that can guide the initiation, intensity, and
duration of therapies for NAS. Such tools could significantly reduce medical costs and improve patient outcomes by
reducing patient time in NICU, reducing nurse load, improving outpatient monitoring, and helping to assist in the
optimization of patient treatments. Critically, we believe such a tool may be able to objectively capture events that may
go unnoticed by nurses or while the infant is sleeping (minor tremors, poor oxygenation, temperature fluctuations,
dehydration).
This proposal seeks to develop, assess, and commercialize interlinked, infant-targeted wearable biosensorsystems
capable of automated digital scoring, continuously monitoring the biochemical, psychological and environmental to
biophysical parameters of opioid-dependent neonates while providing suggestive treatment for NAS. Our team and
partners have outstanding experience in all areas necessary to this investigation to develop a commercial grade
wearable wristband monitoring kit that includes: (1) infant wearable wristband, (2) imaging camera (3) recharging
station, (4) tablet app, and (5) patient portal tailored for professional healthcare providers. Our business unit has
extensive NIH funded experience in wearable biosensing, in the detection of sympathetic nervous system activity in
opioid withdrawal, pediatrics, business development, and intellectual property. Our academic partners have broad
experience in novel biosensor development.

Public health relevance
PROJECT NARRATIVE Rekovar is developing a low-cost wearable monitoring system that integrates wirelessly with a mobile device to allow real- time monitoring of the baby’s physical and physiological state and its ability to sleep, eat, and be nurtured while undergoing neonatal abstinence syndrome (NAS). This device has significant impact in helping reduce both hospital stay and costs as neonates receiving pharmacological treatment are usually in the NICU away from family and non- pharmacological care. Our interest lies with respect to proper neonatal care, where separate procedures occur for essential neonatal needs and needs for neonates undergoing withdrawal, and by using this monitoring device to assess addicted neonates undergoing withdrawal, caregivers are provided the better ability of treating the right neonatal needs with the appropriate procedure in hospitals.